Pulmonary Development and Disease Pathogenesis Training Program

PROJECT SUMMARY/ABSTRACT
Our Pulmonary Development and Disease Pathogenesis Training Program aims to provide advanced research
training by supporting stipends for three pre-doctoral and for five post-doctoral candidates within the
University of Cincinnati College of Medicine (UCCOM) and Cincinnati Children’s Hospital Medical Center
(CCHMC) graduate and post-graduate training programs. The training environment draws upon established,
integrated, innovative graduate and postgraduate programs focused to molecular, developmental, and cell
biology and outstanding clinical, translational programs focused to pediatric and adult pulmonary diseases and
radiological imaging research. The T32 program benefits from strong NHLBI-supported research programs and
brings together more than 36 distinguished, NIH-funded investigators experienced in modern molecular and cell
biology, physiology and imaging strategies to study lung development and diseases. Program faculty have
shared research interests and active collaborations in basic and translational research. Major research themes
include pathogenesis of pulmonary disorders and will also focus to the pulmonary vasculature. Gene expression
among cells, function, and regulation during organ development, injury, and repair are areas of interest. Likewise,
development of biomarkers, imaging, and therapeutics for lung and pulmonary vascular diseases are areas of
excellence. Promising trainees engaged in pre- or post-doctoral training programs are identified and selected on
a competitive basis. PhD and MD/PhD predoctoral trainees obtain their PhD degrees in Graduate Programs in
Developmental Biology, Immunobiology, Biomedical Informatics, Pathobiology and Molecular Medicine or
Molecular Genetics (Biochemistry-Microbiology) at the University of Cincinnati College of Medicine. Post-
doctoral trainees may have an MD or PhD degree, or both, and are recruited to our T32 Mentor laboratories.
Special attention is given to recruitment of minority individuals and physician scientist candidates seeking their
PhD/MD degree. Research training includes mentoring in career development, training in the responsible
conduct of research, reproducibility and scientific rigor, ethics in research, research presentation skills and
various seminars and courses within the graduate and divisional programs in which the trainees and their training
faculty participate. Trainees attend regular research meetings and pertinent seminar series. Program
Administration includes the contact Co-PI and three Co-Principal Investigators, who form the Executive
Committee, and both External and Internal Advisory Committees. The progress of each trainee, quality of
mentors, and overall effectiveness of the program is critically reviewed annually. Trainees will meet with their
Mentor regularly, the T32 Program Director and Co-Directors quarterly, and their Mentoring Committee at least
biannually. This T32 renewal application (Years 25-30) will permit us to continue a program with outstanding
productivity in preparing new investigators to enhance research training and competence in critical aspects of
pulmonary and cardiovascular development and disease pathogenesis.

Public health relevance
PROJECT NARRATIVE This renewal T32 grant application for a Pulmonary Development and Disease Pathogenesis Training Program seeks to continue support to recruit and train outstanding pre-doctoral and post-doctoral candidates, preparing them to advance science and make discoveries that improve the diagnosis and treatment of pulmonary diseases, enabling them to become future research leaders in research and medicine. This Program meets a critical national need to increase the quantity and quality of young investigators who can apply cellular, molecular, and genetic strategies to the study of lung disorders. There is an ever-increasing loss of M.D. and Ph.D. candidates from academic-scientific careers at a time in which unparalleled opportunities exist to identify mechanisms of underlying disease pathogenesis and to develop novel biomarkers, diagnostics, and treatment strategies to improve human health.